Structural and Functional Genomics

STRUCTURAL AND FUNCTIONAL GENOMICS ABSTRACT
The goals of the Structural and Functional Genomics Program (SFG) are aligned and integrated with the vision
and strategies of Moores Cancer Center (MCC) and the UC San Diego School of Medicine. They use the SFG
members’ interdisciplinary strength and expertise in computational biology and genomics to employ a full range
of both structural and functional genomic data to elucidate complex signaling pathways and identify candidate
targets and compounds that can be translated into novel diagnostic and therapeutic targets and clinical interventions.
Approved by the NCI in 1997, the Cancer Genetics Program has evolved to SFG to reflect how, during the past
project period, members have expanded use of multi-omic data types, moved analysis methods to molecular
tumor boards, and elucidated context-dependent molecular states for more targeted treatments. SFG has 36
members from 14 academic departments with $19.2M of peer-reviewed research grant funding (annual direct
costs), $6.3M (33%) of which is from the NCI. SFG members published 714 programmatically aligned articles
since 2013, 11% were the result of intra-programmatic collaborations, 20% were inter-programmatic, and 34%
were inter-NCI Cancer Center. SFG’s specific aims are to: 1) develop innovative, integrative computational
genomic methods that synthesize multi-omic patient and clinical data to drive fundamental and translational
cancer research and to disseminate them to the broader cancer research community; 2) analyze genetic,
transcriptomic, epigenetic, proteomic, immunologic, and metabolomic data to elucidate the underlying biological
pathways and mechanisms of cancer development and progression; and 3) characterize context dependent,
functional states of tumor cells and understand the dynamics of resistance in order to identify novel diagnostic,
prognostic, and therapeutic strategies, including combination therapies. SFG themes are data science and
machine learning, signature and network approaches, and precision therapy. SFG is co-led by Joseph Califano,
a head and neck surgeon and translational researcher who applies genomics to develop novel prognostic
indicators and therapies and Jill Mesirov, a computational biologist who analyzes complex genome-scale cancer
datasets to better understand the underlying mechanisms of cancer, stratify patients, and identify candidate
therapies. Their complementary expertise and highly integrated efforts foster collaboration among the outstanding
SFG investigators who are leaders in their fields with track records of extraordinary productivity and inter-
programmatic collaborations among the MCC research programs. As a result, SFG members have conducted
paradigm-shifting studies defining the broad role of extrachromosomal DNA in human cancers, developed
carcinogen-based mutational signatures across cancer types, demonstrated the role of the microbiome in
hepatocellular cancer development, and produced and maintained key computational methods and tools used
by hundreds of thousands of scientists worldwide.